Predicting the efficacy of therapeutic spinal loading for intervertebral disc regeneration

In Veterans, the most common location of chronic pain is the spine, with back pain frequently caused by
intervertebral disc degeneration. The intervertebral discs are unique in that they are the largest avascular
structures in the body. Cells within the disc therefore rely primarily on diffusive transport from the vessels and
marrow channels in the adjacent vertebral endplate to receive nutrients and expel waste products. Despite the
critical role of trans-endplate transport in disc homeostasis, its association with disc degeneration and
regeneration remain severely understudied. To date, augmenting trans-endplate transport as a therapeutic
strategy for disc regeneration remains largely unexplored compared to traditional tissue engineering or
regenerative medicine approaches. The goals of this proposal are therefore to 1). define how compromised
intervertebral disc nutrition (i.e. trans-endplate transport of nutrients and waste products to and from the
avascular disc) impacts the extent to which therapeutic spinal loading can induce disc regeneration, and 2). to
identify biomarkers of disc nutrition predictive of patient response to clinical rehabilitation strategies. To achieve
these goals, in Aim 1 we will define how trans-endplate transport is altered as a function of intervertebral disc
degeneration severity. Correlations between transport across the boney and cartilage endplate and quantitative
measures of disc degeneration will first be established in human cadaveric tissues. Next, a spectrum of disc
degeneration and accompanying endplate remodeling will be induced in vivo in a rabbit disc puncture model.
Correlations between trans-endplate transport and disc health will also be determined in the rabbit model and
matched to human disease states. In Aim 2, we will then utilize this rabbit model to determine the impact of
compromised trans-endplate diffusion on the capacity of therapeutic spinal loading to regenerate the disc. First,
we will define a non-invasive treadmill exercise routine for rabbits which enhances trans-endplate transport into
the discs. This exercise regimen will then be applied in rabbits with degenerative discs with or without
compromised trans-endplate transport. Control animals will receive no therapeutic loading, and disc regeneration
will be assessed using quantitative measures of disc structure, function, and biology across all experimental
groups. Aims 1 and 2 will establish which stages of degenerative disc disease are associated with compromised
disc nutrition and whether this impacts the capacity of therapeutic spinal loading to have an anabolic effect on
disc health. In human patients with back pain, therapeutic spinal loading may be achieved by exercise or physical
therapy, which are effective in relieving pain in some but not all patients. Therefore, in Aim 3 we will identify
magnetic resonance imaging and serum biomarkers for impaired disc nutrition in human patients with back pain,
and determine if these biomarkers will predict patient response to non-operative treatments for back pain. The
proposed research has the potential to contribute significantly to improving rehabilitation strategies for Veterans
with back pain, in addition to identifying biomarkers predictive of patient response to treatment.

Public health relevance
In Veterans, the most common location of chronic pain is the spine, and the incidence of back pain and disc degeneration is increasing in Veterans at a faster rate than the general public. The goal of this proposal is to first define the physiologic conditions in the spine permissive to regenerating the disc via therapeutic spinal loading, and second to identify imaging and serum biomarkers capable of predicting patient response to non-operative treatments for back pain employing therapeutic loading, such as exercise and physical therapy. This work has the potential to inform patient specific rehabilitation strategies which may improve the overall success of non- operative treatment of chronic back pain, reducing healthcare costs and reliance on opioid pain medications and increasing Veteran quality of life.